Decoding the Brain-Liver Axis: Uncovering mechanisms of host defense

This research proposal seeks to uncover neuronal mechanisms orchestrating metabolic adaptations to
bacterial infections, specifically delineating the pivotal role of the brain-liver axis in modulating metabolic
responses. By combining the methods of neuroscience and immunology, the research aims to better
understand neuronal and hepatic responses to infections. I showed earlier that housing infected mice at
thermoneutrality instead of ambient room temperature better mimics human bacterial infections. For example,
infected mice at thermoneutrality develop severe hyperlipidemia, compromising survival. Here, I hypothesize
that circulating lipids are regulated by neuronal and hepatic mechanisms. In Goal 1, I will look for neurocircuits
in the hypothalamus that might monitor circulating lipoproteins and trigger counterregulatory responses. To do
this, I will use genetic mouse models and chemogenetics to stimulate and inhibit candidate neuronal clusters
during infections. In Goal 2, I will perform an unbiased screen to elucidate hepatic secretome using TurboID,
followed by targeted proteomics. I will target these hepatic factors in vivo to test their role in improving host
survival during bacterial infections. My approaches defining the molecular basis of hyperlipidemia in mouse
models are highly innovative and likely to provide novel insights into how circulating lipid levels determine host
survival.

Public health relevance
This proposal investigates undefined neuronal mechanisms that orchestrate metabolic shifts during bacterial infections. By employing innovative methodologies, the aim is to elucidate the role of the brain-liver axis in modulating metabolic responses, thereby bolstering host survival during infections. By intertwining neuroscience and immunology, this research can unveil new dimensions in host defense strategies, examining both neuronal and hepatic responses to infections.